Deriving high-quality evidence from national healthcare databases to improve suicidality detection and treatment outcomes in PTSD and TBI

PROJECT SUMMARY Post-traumatic stress disorder (PTSD) has complex profiles of co-occurring medical conditions (comorbidities) and is associated with high risk of suicide, particularly among Veterans, in which it is a leading cause of death. There is a critical lack of advancement in PTSD pharmacotherapy, as illustrated by increased use of off-label medications and polypharmacy (multiple drugs used simultaneously). The consequent limited evidence on the relative risks and benefits of treatments creates a crisis in PTSD management. Moreover, PTSD and its major comorbidities [traumatic brain injury (TBI) and suicidality] often remain undocumented in electronic health records (EHR). There is also poor predictability of disease outcomes since there are frequent changes in pharmacological treatment and multiple modifying comorbidities. Our long-term goal is to improve diagnostics, secondary/tertiary prevention, and treatment outcomes of PTSD and its comorbidities via enhanced EHR utilization. To achieve our objectives, we will analyze EHR and administrative claims data from Veterans Administration (VA) and non-VA databases, collectively covering >2M PTSD and >2M TBI patients. Specifically, we aim to: (1) Identify undetected PTSD, TBI, and self-harm from EHRs (using machine learning with and without natural language language processing) to guide health service improvements. (2) Predict PTSD clinical course in the VA population through novel modeling of disease trajectories that account for time-varying treatments and biases (3) Compare the effectiveness of PTSD psychotropic monotherapies, polypharmacy, and psychotherapy to guide the choice of treatment for improved patient outcomes. By enhancing and validating a machine learning approach developed by our team, we will impute unrecorded PTSD, TBI, and self-harm from both datasets, and characterize factors associated with documentation disparities. We will model diseases trajectories with enhanced latent class analysis, focusing on self-harm, substance misuse, and psychiatric hospitalization in PTSD. With Local Control methodology innovations, we will compare the risk of PTSD in veterans with and without comorbid TBI. Finally, we will perform the largest comparative effectiveness studies (to date) of PTSD treatments on >100 monotherapy and polypharmacy regimens plus psychotherapy interventions. These studies will provide high-quality evidence on the risk of hospitalizations, substance misuse, and suicidal acts/self-harm. Successful completion of these investigations will improve the quality of decision making for providers and patients, and guide improved service delivery to the population of veterans and non-veterans with PTSD/TBI, and/or high risk of suicide.

Public health relevance
PROJECT NARRATIVE Post-traumatic stress disorder (PTSD), and its associated conditions (e.g., traumatic brain injury and suicidality) are often underdiagnosed, and have outcomes that are difficult to predict. Treatment of PTSD often involves frequent treatment changes with multi-drug regimens (polypharmacy) and off-label medications for which the relative risks and benefits are largely unknown. To address these problems, we will develop and apply methods to identify undiagnosed patients, predict disease trajectories, and compare the effectiveness of all common PTSD treatments using health records from millions of patients in Veterans Administration (VA) and non-VA databases.